Evaluation and Comparison of Impacts of Flavored Waterpipe Tobacco and Electronic Waterpipe E-Liquid Formulation Variations on Toxicant Yields and Particle Size Distribution in Mainstream Emissions

Project Summary
Waterpipe (WP) smoking has become a popular form of tobacco use in the US, especially among youth and
young adults. These groups are particularly attracted to flavored WP tobacco (WPT). Sweet WPT flavors are
preferred, with fruit flavors in particular leading to initiation and continued WP use, as well as the misperception
of WP smoking as less harmful than cigarette smoking. WPT smoking has been linked to many of the same
adverse health effects as cigarette smoking and releases many of the same harmful and potentially harmful
constituents (HPHCs) as cigarettes, at 10-100 times increased levels. The popularity of flavored WP smoking
has expanded in recent years to flavored tobacco-free alternatives, including electronic WP (EWP). EWP
replaces the traditional WP bowl and heat source with an electronic head filled with flavored, nicotine-containing
liquid (e-liquid), turning the WP into an electronic nicotine delivery system (ENDS). Given the rising popularity of
other flavored ENDS, EWP may pose similar appeal and uptake concerns. EWP may be perceived as a safe
WP alternative, but it has the potential to release the same harmful emissions as other ENDS. Yet nothing is
known about the safety of EWP, or if it offers any harm reductions compared to WPT smoking. Flavored WP
products may play an important role in the direct harms of WP smoking. EWP e-liquids and WPTs both use
flavorants, sweet humectants (propylene glycol and glycerol), and sugars to enhance their appeal. These
ingredients in cigarettes have been shown to form toxic aldehydes and furans during smoking. ENDS research
shows that variations in e-liquid humectant content, as well as the presence of flavorings, can increase aldehydes
emissions. Fundamental knowledge is lacking on the range of toxicants emissions across flavored WP products
and the impact of variations in product formulations on toxic emissions and particle size distribution, a critical
parameter in the delivery of toxicants to the human respiratory system. In order to regulate WP smoking and set
product standards to reduce harms and public health impacts, it is imperative that US Food and Drug
Administration have data to understand the impact of flavored WP smoking on exposure and how exposures
may differ between traditional and alternative WP smoking platforms. This study will fill these gaps by evaluating
and comparing the impact of variations in flavor profiles, humectants and sugar levels, and heating temperatures,
in a variety of commercially available WPTs and EWP e-liquids on yields of HPHCs and other toxicants as well
as particle size distribution in mainstream WP emissions. This will also be the first study to measure toxicant
emissions from EWP use. This study is an essential step in providing robust, fundamental information on WP
product formulations and toxicant emissions to better understand relative harms associated with flavored WP
smoking and establish a knowledge base to inform regulatory actions surrounding WP product standards.

Public health relevance
Project Narrative Flavored waterpipe tobacco smoking is popular among youth and young adults in the US, and a flavored tobacco- free alternative, electronic waterpipe, has recently emerged that turns the standard waterpipe into an electronic nicotine delivery system (ENDS), that may be perceived as safer. Ingredients used to make flavored waterpipe products enhance their appeal, but they can also contribute to toxic emissions to the smoker, yet fundamental knowledge is lacking about the risks from flavored waterpipe smoking, and nothing is known about how electronic waterpipe toxic emissions compare to traditional tobacco waterpipe smoking. This study will help to quantify the harms of flavored waterpipe smoking by determining ranges of toxic emissions across flavored waterpipe products, how variations in ingredients of waterpipe products impact these harmful emissions, and how toxic emissions differ between tobacco and electronic waterpipe smoking, providing new data to inform waterpipe product standards that protect public health.